The Colorado Summer Institute for Research Education in Biostatistics (CoSIBS)

ABSTRACT
The Colorado Summer Institute for Biostatistics (CoSIBS) has extended the reach of the SIBS
network into the western US. In its first five years 26/77 (34%) of participants came from western
states. In keeping with program objectives CoSIBS will continue to inspire the next generation of
biostatisticians and data scientists to pursue advanced study and research careers in the
biomedical, behavioral, and quantitative health sciences. We will recruit an enthusiastic and
diverse group of advanced undergraduate and early-stage graduate students who are interested
in exploring the frontiers of data sciences in the development and application of new methods for
using big data to guide the diagnosis, care, and prevention of disease. The proposal is structured
to provide innovative educational programs using the established research in biomedical data
sciences with NHLBI and NIAID-related research programs that cut across departments at
University of Colorado Denver and affiliated institutions. The proposal draws together a range of
faculty including faculty from the Department of Biostatistics and Informatics, the Department of
Mathematical and Statistical Sciences, and faculty from other departments with research interests
in bioinformatics and data science. CoSIBS will be a 6-week resident summer institute for
approximately 20 advanced undergraduate students or recent graduates. The institute will consist
of approximately 4 hours per day of class and laboratory instruction. The didactic portion will be
at a standard that would be typical of a one-year course in basic statistics as often required in
undergraduate curricula. In addition, students will have mentored projects that are tied to ongoing
research groups at UCD and affiliated institutions. Projects will be co-mentored by faculty with
research interests in biostatistics, statistical genetics, or bioinformatics, and a companion
biomedical investigator from a leading NHLBI-related research group at UCD. The projects will
reinforce course content in study design, data analysis, software applications, and the preparation
of results for publication or presentation to biomedical researchers. An innovative mentored
summer fellowship opportunity will be launched with an institutionally supported stipend for
students from historically underrepresented populations to work with DBI faculty on collaborative
research projects during the weeks preceding and following the 6-week CoSIBS program.

Public health relevance
PROJECT NARRATIVE The Colorado Summer Institute in Biostatistics (CoSIBS) responds to the “Call to Action” to train the next generation of biostatisticians and data scientists. The institute fills an important need in the western US. The program is led by experienced teaching and collaborative faculty with a strong commitment to biostatistics education. CoSIBS has inspired the next generation of biostatistician scientists to meet the long-term needs for new methods, study design, data analysis, and scientific leadership to assure the continued success of biomedical research as a cornerstone of public health practice and patient care.